Phosphoinositide Signaling in Cytosol and Nucleus

Project Summary
The research proposed seeks to reveal mechanisms for spatial phosphoinositide (PI) signaling in the cytosol
and nucleus. These pathways have broad implications for cancer, neurodegenerative disorders, and other
diseases. PI signaling generates seven distinct polyphosphoinositide (PIPn) messengers. EGF and other
agonists activate the class I PI 3-kinase (PI3K)/Akt pathway on membranes that controls cell growth and other
key cellular functions. In nuclei, PIPn pathways are separate from membranes, controlling stress responses that
impact DNA repair, cell survival, and other critical events.
The work on agonist-activated PI3K signaling is focused on the spatial and temporal activation of PI3K,
which generates PIP3 to activate Akt and other pathways. The PI3K pathway plays a key role in cancer both
by agonist activation and by PI3K mutations that hyperactivate the pathway independent of agonists. We show
that the PI3K pathway is incorporated into an IQGAP1 complex, which uses PI to sequentially synthesize PI4P,
PIP2 and PIP3, the latter activating mTORC2, PDK1 and Akt. The utilization of PI suggests that the IQGAP1
complex may function at any cytoplasmic membrane, but dogma states that PI3K signaling occurs at the plasma
membrane. We have shown that agonist-stimulated PI3K signaling is endosomal and is regulated by
interactions with MAP4 and PI3P that spatially targets PI3K to microtubules and endosomes, respectively.
PI3K interactions with MAP4 and PI3P are required for agonist-stimulated signaling. However, the underlying
mechanisms for the assembly of PI3K in these complexes is unknown. Although constitutively active PI3K
mutants that hyperactivate the pathway in cancer still requires IQGAP1, MAP4 and PI3P interactions, the
mechanisms by which these PI3K mutants stimulate the assembly of these complexes needs to be defined.
In contrast to the cytosolic pathway, we have shown that Nuclear PI signaling is separate from membranes
and is mediated by linking PIPns (likely covalently) to PIPn effector proteins (PIPylation) including p53. PIPns are
linked to p53 and sequentially phosphorylated to generate a p53-PIP3 complex that activates nuclear Akt by
assembly of mTORC2, PDK1 and Akt. Remarkably, wild-type (p53wt) and mutant p53 (p53mt) regulate Akt
activation differently, suggesting a mechanism for its tumor suppressor and oncogenic functions, respectively.
Notably, PIPns are linked to many nuclear proteins, indicating a broader “PIPylome”. Remaining questions are
the chemical nature and enzymatic mechanism of the PIPn linkage, the identification of the cellular PIPylome,
and the regulation of PIPylated proteins by PIPns. We have also discovered that PI transfer protein (PITP)s and
PI 4-kinase II (PI4KII) are necessary for PIPylating proteins but the mechanisms are unknown. Moreover,
PIPns are linked to multiple DNA repair proteins and the functional role of PIP linkage in the DNA damage
response will be investigated. Significance- The scaffolded endosomal PI3K activation and PIPylation of
cellular proteins are paradigm-shifting and have vast implications for biology and therapeutics.

Public health relevance
Project Narrative Agonist-activated PI3K signaling and nuclear phosphoinositide (PI) signaling in response to stress have fundamental roles in many cellular functions and diseases including neurodenerative disorders and cancer. We have discovered the regulation of PI3K signaling on cytoplasmic membranes by a scaffolding mechanism which brings all components of the PI3K pathway in close proximity for concerted and spatial generation of the second messenger phosphatidylinositol-3,4,5-trisphosphate. In the nucleus, PI messengers are linked to proteins such as p53 and PARP1 and control many functions. The discovery of these distinct PI signaling pathways and their molecular characterization have profound implications for biology and therapeutics.